A Novel, Personalized Innovation to Reduce Health Disparities for Rural ADRD Care Partners: CareVirtue Resource Connection.

PROJECT SUMMARY
Care partners of people living with Alzheimer’s Disease and Related Dementia (ADRD) in rural areas
experience disproportionate caregiving burden and experience lower social support than their urban
counterparts, which are impacted by Social Determinants of Health (SDOH) related to the physical and social
isolation associated with providing care for a person living with ADRD. Currently available technology lacks
focus on the unique needs of rural ADRD care partners.
In response to this critical gap, our team took first steps with a successful Phase I project (R43AG080849); the
project included an assessment of resource needs for rural ADRD care partners, co-designing a prototype
intervention with rural ADRD care partners, and demonstrating feasibility of the prototype intervention (the
CareVirtue Resource Connection). The Resource Connection prototype assesses individual rural ADRD
care partner needs, delivers personalized resources based on their needs and geography, and stores
personalized resources in a digital library for easy accessibility.
Phase I successfully established prototype feasibility, providing a solid foundation for the proposed
Phase II project. Continuing to follow the NIH Stage Model, we will (i) operationalize the prototype
intervention for use by HCBS providers for easier implementation and (ii) demonstrate the feasibility of the
operationalized intervention. Our Phase I results provide a strong foundation for this proposed Phase II
project, and following the NIH Stage Model we will: (i) co-design with rural community partners an AI-assisted
ADRD resource matching and referral system and (ii) demonstrate the feasibility and acceptability of these new
features. Our long-term goal is to commercialize an evidence-based intervention that can overcome
barriers encountered by rural ADRD care partners.
Our team (Indiana University, University of Wisconsin-Madison, and CareVirtue) has deep experience in ADRD
caregiving, user-centered design, software development, AI ethics and AI-enabled framework design, and
product commercialization. Our partnerships with HCBS providers across multiple rural communities (North
Carolina, Tennessee, South Dakota, Utah, Florida Panhandle) are poised to engage with rural ADRD care
partners for this project. If successful, this Phase II project will result in a user-centered intervention designed
for both rural ADRD care partners and HCBS providers to overcome common barriers, reduce caregiving
burden, and reduce social isolation for rural ADRD care partners.

Public health relevance
PROJECT NARRATIVE Care partners of people living with Alzheimer’s Disease and Related Dementia (ADRD) in rural areas experience disproportionate caregiving burden and experience lower social support than their urban counterparts. Despite this, currently available technology lacks focus on the unique needs of rural ADRD care partners. In this proposed Phase II project, we will operationalize the CareVirtue Resource Connection and demonstrate feasibility to establish a user-centered intervention designed for both rural ADRD care partners and HCBS providers that can overcome common barriers, reduce caregiving burden, and reduce social isolation for rural ADRD care partners.